Science in a Culture of Mentoring

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. To improve the public's recognition of efforts to understand diseases and the ability for researchers to?access biospecimens from a diverse complement of individuals.